UNITS: The UNC / UT National Clinical Trials Network Group Integrated Translational Science Production and Consultation Center

PROJECT SUMMARY/ABSTRACT
In the current era of Precision Medicine, molecular studies are an integral component of cancer
clinical trials. Amongst the most powerful techniques connecting targeted therapies to specific
patients are assays that interrogate nucleic acids (DNAseq and/or RNAseq), which are now most
typically done using massively parallel sequencing (MPS). RNAseq offers an extremely powerful
approach for querying the tumor genome, and gene expression profiles have proven value in
providing predictive information, prognostic information, and also critical information on the tumor
microenvironment. In addition, DNA based approaches can also be clinically informative in
detecting somatic small sequence alterations (single nucleotide variants (SNVs), insertions, and
deletions) as well as larger structural variations including gene rearrangements, loss of normal
DNA sequences, or sequence gains (amplifications). Alternatively, sequencing assays can target
DNA from noncancerous cells to address additional questions including identification of familial
predisposition, and genotyping of drug metabolizing enzymes of therapeutic importance.
Through continuation of this Project, the UNG / UTHSC UNITS team will provide high volume
sequencing in a regulatory compliant manner from day one of the extension. As a world leader in
the production of human RNA-based cancer data, from both frozen and FFPE, including RNA
sequencing and targeted RNA quantification, RNA-based assays are offered within a compliant
setting. We are also highly experienced with common, and complex, DNA-based assays and offer
these as well. Aims 1 and 2 of this proposal involve providing a compliant mechanism for high
sample throughput for RNA- and DNA-sequencing from samples provided from multi-institutional
cooperative group trials. RNA sequencing will utilize total RNA sequencing to provide
comprehensive coverage. DNA sequencing will be offered for both whole exome and targeted
capture by MPS. The third aim is to develop and provide data sharing formats and an
infrastructure for the proper dissemination of clinical trial sequence-based patient information,
which is needed is this era of Big Data.

Public health relevance
PROJECT NARRATIVE The adoption of genomic medicine in the clinic has incredible potential to clarify disease origins, improve diagnosis, and usher in the era of personalized medicine for cancer patients. In this extension proposal, we plan to continue to provide methods, know-how, and robust technologies, in association with clinical trial specimens, for tumor samples to be evaluated for genomic changes that may be targeted by molecular-based therapies.